Metabolic mechanisms of glioma progression

PROJECT SUMMARY
Gliomas represent 80% of the 26,000 newly diagnosed cases of malignant brain and central nervous system
tumors in the United States each year and are among the most lethal and treatment-resistant human cancers.
There are no curative treatments for glioma, and high-grade gliomas carry a particularly dismal prognosis, with
a median overall survival of just 16 months. Therefore, there is a dire need to generate new insights into the
pathological mechanisms driving glioma formation and progression and translate this information into new
treatment strategies. Despite advances in our understanding of the transcriptional and genomic aberrations
associated with this disease, our knowledge of the metabolic alterations that define distinct subsets of glioma is
relatively limited. To address this issue, we performed mass spectrometry-based quantification of 564 unique
metabolites in a collection of 91 adult surgical brain tissue specimens, representing high-grade gliomas, lower-
grade gliomas, brain metastases, and non-malignant brain tissue. We found evidence of widespread
reprogramming of an anabolic metabolism pathway in high-grade gliomas relative to lower-grade gliomas and
non-malignant brain specimens. Intriguingly, metabolic reprogramming in high-grade gliomas displayed clear
parallels with a well characterized inborn error of metabolism. In patients with congenital mutations affecting
this pathway, aberrant metabolite secretion from neural cells causes neuronal hyperexcitability and leads to
seizures that characterize this disease. Local neuronal hyperexcitability and seizures are also features of high-
grade gliomas. In these tumors, neurons communicate with tumor cells through paracrine signaling and
electrochemical stimulation mechanisms that promote glioma growth. In turn, glioma cells signal to neurons to
foster their excitability, albeit through mechanisms that are not fully understood. Based on these findings, we
hypothesize that aberrant metabolite secretion represents a key mechanism underlying glioma-neuron
crosstalk in high-grade gliomas and that this phenotype is crucial for brain tumor progression. We will test this
hypothesis through three specific aims. First, we will dissect the molecular basis for metabolic reprogramming
and aberrant metabolite secretion in high-grade gliomas, testing the idea that imbalanced enzyme expression
is necessary and sufficient to trigger these events. Second, we will determine the impact of aberrant metabolite
secretion by glioma cells on excitability of the tumor microenvironment by measuring neuronal activity and
glioma cell depolarization. Third, we will define the role of metabolic reprogramming and aberrant metabolite
secretion in glioma pathogenesis by deactivating these mechanisms and evaluating the effect on intracranial
glioma xenograft growth. Together, these studies may reveal a new intercellular communication pathway
linking glioma cells and neurons, representing a vulnerability that could be exploited for brain tumor therapy.

Public health relevance
PROJECT NARRATIVE To address the urgent need for new insights into the biological processes that promote glioma, the most common type of malignant brain tumor, we measured metabolite levels in a collection of human glioma samples and non-cancerous brain tissues. We identified a metabolite that is highly enriched in aggressive gliomas and we now seek to reveal how it accumulates in these tumors and the role it may play in promoting interactions between glioma cells and neurons. Because interactions between glioma cells and neurons are known to be critical for brain tumor growth, our work may deepen our understanding of these interactions and inform new approaches to treat glioma.